TRD1: Quantitative Imaging of Physiological Markers

TRD 1: Quantitative Imaging of Physiological Markers
Lead Principal investigator: Hanzhang Lu, Professor of Radiology
Co-investigators: Jim Pekar, Qin Qin, Jun Hua, Peiying Liu, Wenbo Li
This TRD will develop physiological MRI techniques that provide quantitative and
biologically interpretable measures of the brain. We will develop methods to probe basal
physiological parameters including cerebral blood flow (CBF), bolus arrival time (BAT),
oxygen extraction fraction (OEF), and blood-brain barrier (BBB) permeability. We will
also develop techniques to assess dynamic physiological parameters including
cerebrovascular reactivity (CVR), arterial pulsatility, and vascular compliance (VC). We
will achieve these goals through systematic development of novel pulse sequences,
models, and data processing methods. To allow these sophisticated measures to be
obtained with clinically practical time, fast acquisition methods will be integrated into our
techniques such as compressed sensing, multi-band/simultaneous-multi-slice, parallel
imaging, variable-density spiral sampling, and stack-of-stars 3D acquisition. Multi-
contrast imaging (e.g. combining physiological with anatomic imaging) will be achieved
by MR Fingerprinting (MRF). To improve the speed and reliability of parametric
estimations, especially for MRF-type of acquisitions, deep learning methods will also be
applied. To ensure readiness of these techniques for biomarker testing, small-scale
standardization and compatibility assessments will be performed which include intra-
session, inter-session, inter-vendor, inter-rater test-retest, and cloud-based MRI data
processing. The development of the techniques will be conducted with close
interactions (so-called “push-pull relationship”) with the Collaborative Projects (CPs) and
in collaboration with other TRDs. Additionally, these tools, once fully tested, will be
disseminated to the Service Projects (SPs) and other interested researchers.

Public health relevance
This TRD will develop new MRI techniques to provide researchers and clinicians with the ability to assess the brain’s physiology, such as blood supply, brain’s oxygen consumption, leakage of blood-brain barrier, blood vessel’s responses to carbon dioxide and blood pressure changes. To achieve these goals, we will develop new MRI techniques and integrate other state-of-the-art technologies. These methods will be made available to a variety of NIH-funded projects led by investigators working on different MRI scanners and for them to study several devastating brain diseases.